SToP Cancer SPORE: Career Enhancement Program

CAREER ENHANCEMENT PROGRAM: ABSTRACT
The primary objective of the Career Enhancement Program (CEP) of the UNC Pancreas SPORE is to augment
the career development of a diverse group of faculty members who will focus on pancreatic cancer research.
This will be accomplished by 1) providing financial support to develop and enhance the research effort of these
faculty and 2) to provide both clinical and laboratory mentoring for investigators who are new to the field. We
intend to foster the research careers of translational investigators working in pancreatic cancer. The CEP will
select investigators for support from the entire spectrum of translational research in pancreatic cancer; including
those working in public health areas of prevention and early detection, diagnosis and other pertinent areas of
population science; basic science investigators working to translate their findings to patient care in the clinic and
translational/clinical investigators working to improve the outcome for patients with pancreatic cancer. We will
support highly qualified investigators who are new to the field of pancreatic cancer with a focus on early career
or mid-career investigators transitioning to work in this area.
The CEP is led by Jonathan Serody MD Associate Director for Translational Science at the Lineberger
Comprehensive Cancer Center and Elizabeth Thomas Professor of Medicine, Microbiology and Immunology.
The co-leaders are supported by the CEP Advisory Committee (CEPAC) that is chaired by the co-leaders and
includes Melissa Troester, PhD (Population Sciences), Anne Menkens, PhD (Administration), Antonio Baines
PhD (CEP Minority Advisor, NCCU), Albert Baldwin, PhD (Director DRP), and Andrea Hayes-Jordan (Pediatric
Surgery) and our patient advocates. Applicants will be selected from the highly qualified pool of investigators at
the University of North Carolina Chapel Hill and North Carolina Central University an Historic Black College and
University in Durham NC which has a strong scientific relationship with the Lineberger Comprehensive Cancer
Center and has a large African American and Latino population of students and postdoctoral fellows. Recruitment
of underrepresented minorities, disabled individuals, and women to pancreatic research will be emphasized and
will be the focus of Dr. Baines’s efforts on the CEPAC.
Financial support will be for an initial period of one year, that will be renewable if there has been appropriate
translational progress. We will collaborate with our partner institutions to strengthen multi-institutional
collaborations as the CEP matures.

Public health relevance
CAREER ENHANCEMENT PROGRAM: PROJECT NARRATIVE The Career Enhancement Program of the UNC Pancreatic cancer SPORE prepares the next generation of translational pancreatic cancer researchers.